Research Expanding Access to Child Health (REACH)

PROJECT SUMMARY
To improve the health and wellbeing of our nation’s children, it is essential to transform pediatric health care to
address the complex social ecological factors that persistently hamper access to child health and contribute to
pervasive health inequities. The overall goal of the Research Expanding Access to Child Health (REACH) Center
of Biomedical Research Excellence (COBRE) is to strengthen pediatric healthcare delivery research infra-
structure at the Nemours Children’s Hospital-Delaware (NCH-D) and establish robust programs of research,
using stakeholder-engaged approaches to develop acceptable, feasible, and effective interventions and models
of care to achieve health equity. The REACH Center will soon conclude its second year of funding and it has
seen great success. Two research cores -- PROMISE (Pediatric Research Optimizing Methods in Stakeholder
Engagement) and IMPACT (Intervention Methods: Provision and Connection through Technology) – are
providing research infrastructure to investigators across Delaware. Project funding, research management
support, and mentorship focused on the transition to independence (Launch mentorship) has been provided to
six investigators to date with another three pilot projects starting in March 2024. Additionally, career development
and leadership training (Lead mentorship) has been provided to independent REACH Center investigators to
foster their promotion and retention. This application for an Administrative Supplement to Recognize Excellence
in Diversity, Equity, Inclusion, and Accessibility (DEIA) Mentorship will allow for an expansion of our Lead
mentorship program to focus on issues of DEIA in our Center. Lead is overseen by Melissa A. Alderfer, Ph.D.,
MPI of the REACH Center, who will serve as PI/PD for this supplement. Dr. Alderfer is an experienced mentor
committed to her mentee’s scientific and professional development and career progress. As a woman and first-
generation scholar from a disadvantaged background, she has sought out and cultivated the development of a
diverse group of mentees and prioritized establishing an inclusive research environment within our Center. The
supplemental funds will expand these efforts in three ways: Aim 1) Extend the Lead mentorship program to
REACH Center staff and trainees from diverse backgrounds and provide culturally aware mentorship training to
all; Aim 2) Expand our efforts to foster and fund health equity research led by investigators from diverse
backgrounds through targeted mentorship; and, Aim 3) Establish a mentored research experience to introduce
cohorts of diverse trainees and community members to biomedical research. It is widely accepted that diversity
at all levels of the scientific workforce enhances the innovation, conduct, quality, and impact of research. DEIA
is particularly important in the REACH Center given our focus on reducing health disparities and social inequities.
The proposed enhancements to our Lead Mentorship Program are within the scope of our active award, will
have a broad impact on our training environment at NCH-D, and will catalyze the ability of the REACH Center to
propel scientific knowledge and clinical practice forward to equitably improve health for all children.

Public health relevance
PROJECT NARRATIVE The REACH (Research Expanding Access to Child Health) Center of Biomedical Research Excellence is providing the infrastructure needed for researchers across Delaware to join with stakeholders and community partners in the development, evaluation, and implementation of innovative interventions and models of care to overcome the complex socio-ecological factors responsible for pediatric health disparities. This Administrative Supplement to Recognize Excellence in Diversity, Equity, Inclusion, and Accessibility (DEIA) Mentorship will allow us to expand our REACH Center mentorship program to support a broader and more diverse group of investigators, staff, and trainees, cultivating their skills, benefiting the quality and impact of our research, and building a diverse biomedical research workforce. With this additional support, the REACH Center will propel scientific knowledge, technical capabilities, and clinical practice forward to improve healthcare for all children and families across Delaware with broad implications nationally.